Administrative supplement for Early Drug Development Opportunity Program (EDDOP)

ABSTRACT
This proposal addresses Dartmouth Cancer Center’s (DCC) ability to conduct and participate in
cancer early phase clinical trials through the Experimental Therapeutics Clinical Trials Network
(ETCTN) of the National Cancer Institute (NCI). It serves as a comprehensive response to the
NCI’s P30 Cancer Center Support Grant Administrative Supplement, to NCI-designated Cancer
Centers previously participating in Create Access to Targeted Cancer Therapy for Underserved
Populations (CATCH-UP), to promote continued collaboration with CTEP’s ETCTN under
funding opportunity PA-20-272. DCC’s objectives as an NCI-designated comprehensive cancer
center are aligned with ETCTN’s goals to conduct early phase clinical treatment trials across a
broad range of cancers and diverse patient populations, with an emphasis on rare diseases.
DCC was approved through peer review for the NCI Cancer Center’s Early Phase Clinical
Research component of NCI Center Grants. Dartmouth is a Lead Academic Participating Site
in the NCI National Clinical Trials Network. We currently are not affiliated with any ETCTN UM1
grantees that are funded to conduct studies of NCI-IND agents with a phase 1, and more
recently also with phase 2, emphasis. Our proposal utilizes a pre-existing and functioning
cadre of established inter- and multidisciplinary investigators at DCC, The Geisel School of
Medicine at Dartmouth (Geisel), Dartmouth Health (DH), and the Thayer School of Engineering
at Dartmouth, which share common clinical, basic science and clinical translational research
interests in cancer treatment and imaging. We have core laboratories and an infrastructure that
supports the conduct of a wide spectrum of correlative science studies typically associated with
early phase trials and basic research in cancer biology, immunology, and imaging. As an
academic NCI-designated comprehensive cancer center, we are well-positioned to provide
scientific leadership in developing and conducting innovative early phase studies of anti-cancer
agents held under CTEP’s IND, as well as substantial numbers of patients eligible for accrual to
clinical trials conducted across the entire ETCTN.

Public health relevance
NARRATIVE: Our geographic location provides access to clinical trials to a rural underserved population. Our overarching mission is to participate, and be a leader, in the ETCTN’s collaborative clinical research program of early phase clinical trials designed to provide a sufficiently unequivocal signal of clinical benefit to justify definitive large multi-institutional phase 3 trials to demonstrate improved outcomes and change standards of practice.